Pathways to Loneliness in First-Episode Psychosis: Testing the Sociodevelopmental Model

PROJECT SUMMARY/ABSTRACT
Loneliness, the subjective feeling of social disconnection, has significant adverse effects on both physical and
mental health, including increased anxiety, depression, risk for suicide, and even premature death. These
outcomes are particularly severe among youth (ages 14-30) experiencing a first episode of psychosis (FEP),
where loneliness may serve to worsen symptoms and delay recovery. Further, symptoms of FEP interact with
unique developmental challenges during a time where social interaction is salient: youth with FEP often report
high rates of stigma, which may compound and/or elicit experiences of loneliness. Positive symptoms (e.g.,
paranoid delusions) could lead to rejection from others (external stigma), while internalized stigma could worsen
negative symptoms, such as amotivation, furthering social isolation and loneliness. Current research in
loneliness in FEP is hindered by a lack of longitudinal data, examination of contextual factors influencing
loneliness in youth (i.e., stigma), and limited consideration of developmental considerations. This project
proposes a novel mixed-methods approach to investigate daily experiences of loneliness, stigma, and symptom
severity in FEP. The project uses advanced quantitative methods to analyze group-level and individualized
relationships between loneliness, stigma, and FEP symptom severity through the analysis of ecological
momentary assessment (EMA) data. Additionally, a qualitative portion of the study will explore how the
interruption of developmental milestones (e.g., as a result of hospitalization or absence from school or work)
influences experiences of loneliness during an important time of social and personal development. The project’s
goals are to (1) characterize the relationship between loneliness, stigma, and psychosis symptom severity at
baseline, (2) explore temporal and contextual dynamics between loneliness, stigma, and psychosis symptom
severity through analysis of longitudinal EMA data, and (3) highlight the age-related concerns of youth with FEP
through the integration of interview data underscoring lived-experience perspectives. By taking into consideration
stigma and other social and developmental factors, this research aims to deepen our understanding of loneliness
in FEP, addressing a significant gap in our current knowledge. This project will also serve to enhance the
applicant’s skills in rigorous mixed-methods research in early psychosis, through mentored training in social
determinants of psychosis symptom severity, in tandem with sophisticated quantitative modeling and qualitative
analysis. This novel research and in-depth training plan empowers an independent program of future research
contributing to the investigation and development of more effective early intervention efforts in psychosis.

Public health relevance
PROJECT NARRATIVE The proposed project investigates the urgent issue of loneliness in youth experiencing a first episode of psychosis. Those with a first episode of psychosis face barriers to illness recovery during a crucial developmental period as the result of social disconnection, including loneliness. Through a mixed-methods, theory-informed approach, this project aims to elucidate the relationship between loneliness and psychosis symptom severity, examining the critical impact of mental health stigma on social experiences in daily life. This knowledge will address current gaps in research on loneliness at the earliest stages of psychotic illness, offering an avenue to tailor early intervention services for youth that target loneliness following a first psychotic episode, while highlighting both clinical and social factors that may delay remission.